Regulation of Natural Antibody-Producing B-1 Cells

Summary
The selective absence of IgM in humans, a rare genetic disorder, is linked to enhanced autoimmunity, as well
as increased risk of infections, consistent with studies in mice. In mice, most spontaneously generated “natural”
IgM is produced by broadly autoreactive B-1 cells, cells that develop in multiple waves during the fetal and early
neonatal period, through a developmental path that is controlled in part by epigenetically regulators of fetal
hematopoiesis (Lin28/Let7). Their distinct developmental processes select for a unique and self-reactive Ig-
repertoire that characterizes these B-1 cells, which in turn defines their transcriptional profile. Our recent studies
have identified two distinct subsets of nIgM-secreting B-1 cells in bone marrow and spleen: B-1 plasma cells (B-
1PC) and non-terminally differentiated B-1 cells (B-1sec). The distinct pathways these cells take to becoming
nIgM-producing cells, and thus the mechanisms controlling these autoreactive, yet functionally critical nIgM-
secreting B cell subsets, is largely unknown. Filling this gap in knowledge is important as it may identify novel
control mechanisms of B cell-mediated autoimmunity, guide the identification of human B-1 orthologues, and
eventually their manipulation for therapeutic or prophylactic uses. We have been involved in a large-scale
phenotypic reverse genetics screening effort of 14 weeks-old C57BL/6 mice with single, known gene deficiencies
(“knockouts”), generated by an NIH-supported consortium. We used two multicolor flow cytometric panels to
screen the spleens of 4,390 mice (3F/3M mice per genotype) and 617 distinct genotypes for changes in leukocyte
populations. Using an unbiased data analysis approach, we recently identified 18 knockout mice with significant
and selective changes in splenic B-1 cells. 17 of those have not previously been shown to affect B cell
development or differentiation. One, Rac-2 was previously shown to affect B-1 and marginal zone B cells
demonstrated the validity of our approach. Aim 1 of this application is to explore the functional impact of 7 of
these novel genes on the development of B cell subsets, especially the nIgM-secreting B-1PC and B-1sec in
spleen and bone marrow and their B cell extrinsic and intrinsic expression. In Aim 2 we propose to study the
functional impact of the genes, by measuring antibody production from birth – 14 weeks of age by ELISA and
ELISpot and assessing the repertoire via auto-antigen array. Neonatal allotype-chimera approaches will
determine to which extent validated genes regulates B-1 cells and their differentiated nIgM secreters in a B cell-
intrinsic versus extrinsic manner. Expected results would identify novel genes and/or regulatory pathways
selectively responsible for the regulation of natural Ig production. This would enable future follow-up studies to
define the molecular mechanisms by which each of the identified genes regulate these cells and might help to
develop gene-signatures that could aid the identification of B-1 orthologues in humans or other model species.
It may also reveal pathways that more broadly control antibody production by autoreactive B cells.

Public health relevance
Narrative Natural IgM antibodies are part of the immediate early defense from infections, but their presence also reduces the incidence of autoimmune disease. This grant proposal aims to identify novel genes that regulate the development and/or maintenance of the cells generating these antibodies. Gaining this knowledge is critical for harnessing the potential broad protective powers of this antibody through development of vaccines and/or therapeutics. It may also identify new pathways that can control autoreactive B cells.